Optimizing the Clinical Management of Polypharmacy for Children with Medical Complexity

PROJECT SUMMARY/ABSTRACT
Optimal health for children with medical complexity (CMC) often depends on exposure to pediatric
polypharmacy (≥5 concurrent medications). Medication-related problems (MRPs), like inappropriate therapy,
undertreated symptoms, or adverse drug events, can lead to emergency visits or hospitalizations. Yet, during
routine clinical care for CMC, polypharmacy is infrequently assessed and rarely managed comprehensively. To
improve medication-related patient outcomes, safety, and value, a new approach is needed to manage
polypharmacy in the priority population of CMC. Pharmacist-led medication therapy management (MTM) is a
proven and effective tool for managing adult and geriatric polypharmacy. Our scientific premise is that a
structured pharmacist-led Pediatric Medication Therapy Management (pMTM) intervention will improve the
proactive management of polypharmacy by directly addressing major gaps in current practice. The
implementation of pMTM to address pediatric MRPs thus represents innovation based on an established
foundation. We propose a hybrid type 2 randomized controlled trial (RCT) of a pMTM intervention. This 5-year
study compares the effectiveness of a pMTM intervention to usual care for reducing the primary outcome of
MRPs, as well as the secondary outcomes of symptom burdens and acute healthcare utilization. In Aim 1, we
use a hybrid type 2 RCT to quantitatively measure reach and effectiveness of the pMTM intervention. We will
recruit CMC with polypharmacy and their parents within an academic center’s outpatient complex care
program that serves >5600 CMC annually. In Aim 2, we will quantitatively and qualitatively examine important
patient and parent characteristics that modify the effectiveness of the pMTM intervention. In Aim 3, we will
assess adoption, implementation, and potential for maintenance of the pMTM intervention by healthcare
providers, including program replication costs. The University of Colorado Anschutz Medical Campus provides
a unique research environment enabling the conduct of pediatric polypharmacy research, supported by
collaborative research partnerships between the Adult and Child Center for Health Outcomes Research and
Delivery Science (ACCORDS), the Skaggs School of Pharmacy and Pharmaceutical Sciences, and the
Children’s Hospital Colorado Special Care Clinic for children with medical complexity. Dr. James Feinstein, an
expert in pediatric complex care and polypharmacy research, will lead an experienced team of co-investigators
including, Dr. Allison Kempe (pragmatic trials and implementation science), Dr. Chris Feudtner (health services
and complex care research), Dr. Lucas Orth (pediatric pharmacy), Dr. John Rice (biostatistics and longitudinal
methods), Dr. Megan Morris (qualitative research), and Dr. Mark Gritz (economic analysis) to complete the
proposed research. If pMTM is proven effective, it could be rapidly disseminated nationally as a model for
pharmacist integration into outpatient complex care programs and it could have enormous impact on the public
health of CMC by preventing medication-related safety issues, attendant morbidity, and associated costs.

Public health relevance
PROJECT NARRATIVE Pediatric polypharmacy (defined as ≥5 concurrent medications) is a major public health problem with high prevalence among the priority population of children with medical complexity. Pediatric polypharmacy is necessary for symptom and disease management, but major opportunities exist to improve outpatient medication management, safety, and value. We will conduct a hybrid type 2 randomized controlled trial to study the effectiveness of a structured pharmacist-led Pediatric Medication Therapy Management (pMTM) intervention on improving the proactive management of polypharmacy by reducing medication-related problems (MRPs), with an evaluation guided by the RE-AIM (Reach, Effectiveness, Adoption, Implementation, and Maintenance) framework to determine whether pMTM could be transformational for optimizing polypharmacy among children with medical complexity.